HUMAN T LYMPHOCYTE FUNCTION IN SLE AND CONTROL POPULATIONS

To determine whether the variable levels of interleukin 2 produced by T lymphocytes with patients having active SLE are genetically determined.